Validating Mouse Models of Prostatic Hyperplasia

ADMINISTRATIVE CORE: SUMMARY
This Administrative Core provides support and oversight for the P20 FORWARD Center. The Core will have
two major tasks: 1) to facilitate the administration and higher-level management of the Center, providing access
to expertise and resources as needed by the ESIs to achieve their immediate research goals, and 2) to support
the career development of the ESIs through the successful completion of the project and the development of
emergent new research proposals. The Core will also facilitate interactions with the NIDDK CAIRIBU and the
broader research community as well as compliance with appropriate local and federal regulations and data
availability requirements. The Core Director provides advice, encouragement, and resources, but the overall
research project was developed, and will be executed, primarily by the three co-investigator ESIs. The Core will
provide a central communications hub between the ESIs who are working in three different locations, providing
easy access to videoconferencing for both group discussions and communication with outside experts and with
the broader benign urology research community. All three ESI, as well as the PI, have previously been, and
continue to be, involved with CAIRIBU and are familiar with the organization and its various in-person and online
meetings. The Core Director will ensure that the ESIs attend scheduled CAIRIBU meetings, will arrange for
scientific updates by Center investigators at the CAIRIBU Annual Meeting, and facilitate ongoing communication
with the CAIRIBU Interactions Core providing an interface with NIDDK. The Research Project will provide a
molecular and cellular description of mouse models of prostate inflammation and hyperplasia, their individual
transcriptomic, histologic, and functional characteristics, and the parallels to, and differences from, specific
aspects of human BPH. The project addresses a major knowledge gap and will generate data that will support
the development of new funding proposals to support funding proposals. The Core Director will provide access
to resources including human patient transcriptomic databases and annotated human clinical samples that will
be used to compare mouse models to human BPH. The Administrative Core will ensure that studies are
completed and submitted for publication in a timely manner. The Core will be responsible for ensuring that data
are deposited in a publicly available and easily understood form in a timely manner and will publicize the
development of a database that can be interrogated through an RShiny application to be developed in the project.
The major long-term goal of this Center is to help the ESIs to move to independent research careers. The project
will develop data that can be used to support funding proposals. Such proposals require rigorous development
to allow them to succeed in the review process. As such, the Administrative Core will oversee the establishment
and regular meetings of committees of appropriately skilled and experienced individuals to provide relevant
advice and insights on proposals as they are developed and through the submission process.